External Research Resources Support and Dissemination (R&D) Core

Abstract – External Research Resources Support and Dissemination (R&D) Core – Core D
The benefits of new knowledge and innovative research resources that improve understanding of ADRD care
and consequences will not reach their full potential without being accessed, understood, and acted upon by
appropriate audiences including the lay public, government and other policy-makers, and the scientific
community. The goal of the Hopkins’ Economics of Alzheimer’s Disease & Services (HEADS) Center
External Research Resources Support and Dissemination (R&D) Core (Core D) is to disseminate and
translate findings and research resources so that they reach diverse internal and external governmental,
advocacy, and scientific audiences who are positioned to influence policy and clinical practice. To meet its
goals, the R&D Core has the following three Specific Aims: SPECIFIC AIM 1: To build research capacity and
promote ADRD economics and health services research through workshops focused on developing skills
using the National Health and Aging Trends Study (and National Study of Caregiving) for promising early
stage investigators in the field that address cross-cutting Center themes relating to family and unpaid
caregiving (in Year 02) and disparities (in Year 04). SPECIFIC AIM 2: To establish a strategic bi-directional
pipeline for developing, disseminating, and translating HEADS research and research resources through
engaging a Translation Advisory Panel of external leaders with diverse perspectives in ADRD-related policy,
advocacy, and health care delivery. SPECIFIC AIM 3: To translate and disseminate research results and
resources to internal and external audiences through multiple modes of communication by developing a
dissemination and translation infrastructure for extending reach and awareness of Center resources and
findings through print- and web-based approaches, social media, webinars, and traditional methods of
research dissemination, such as policy briefs and peer-review publication. The Core is structured to
maximize communication and networking among all Center components and with the larger Hopkins and
external scientific, policy, and service communities. The R&D Core will provide the leadership to engage
diverse audiences – e.g., policy-makers, members of the advocacy community, and key organizations that
are committed to improving the lives of persons with ADRD and their families – with the ultimate goal of
increasing the value of research evidence so that it is understandable and accessible and used by varied
stakeholders to guide strategic decision-making.